Phosphine-Catalyzed Annulations and their Applications

PROJECT SUMMARY
The overarching goal of this application is the development of new catalysts and reactions to empower the
chemical synthesis of medicinally relevant natural product targets and pharmaceuticals. Specifically, we
formulate a rationale for designing strained and bridged bicyclic phosphine oxides that can readily be reduced
back to phosphines in situ. A novel [2.2.1] bicyclic phosphine oxide has already exhibited reactivity, in both
catalytic Wittig and Staudinger reactions, superior to that of the best alternatives known at the time of its
invention. Theoretical investigations predicted, and we have indeed proved experimentally, that the proposed
[2.1.1] bicyclic phosphine oxides would be even more reactive than any other known phosphine oxides.
Considering the ubiquity of reactions driven by the formation of phosphine oxides, and their environmental
consequences, our proposed research should have significant impact on organic synthesis. Our inspiration for
the [2.2.1] bicyclic phosphine oxides originated from the Hyp-derived chiral phosphines (“HypPhos”) that we
developed during the last funding periods. Building on the greater faculty of the [2.2.1] bicyclic phosphine oxides,
we will apply the HypPhos (oxides) to catalytic asymmetric Staudinger, Wittig, Mitsunobu, and Appel reactions.
The HypPhos (oxides) have already displayed tremendous potential in facilitating enantioselective Mitsunobu
and Appel reactions and the first successful example of a catalytic asymmetric Staudinger/aza-Wittig reaction.
We have also created new [2.2.1] and [2.1.1] bicyclic chiral phosphines (“CarvoPhos”) from carvone. The
CarvoPhos (oxides) should be versatile catalysts because both enantiomers of carvone are naturally abundant.
We will also explore the modularity of our approach to chiral phosphines in the syntheses of (o-hydroxybenzyl)-
HypPhos and -CarvoPhos oxides for redox-neutral phosphine oxide-catalyzed Mitsunobu and Appel reactions.
To build upon the exciting results of enantioselective allene–imine [4+2] annulation, we also put forth a unique
strategy for the assembly of akuammilline alkaloids. Capitalizing on the capacity of phosphines to function both
as organic catalysts and as ligands on homogeneous transition metal catalysts, we have devised a tandem
Michael−Heck reaction of haloalcohols and activated acetylenes for the assembly of 5- and 6-membered carbo-
and heterocycles. One particular Michael−Heck process, employing γ-haloallyl alcohols, is a powerful tactic for
assembling furans with almost any substitution pattern, while also providing access to several structurally
disparate furan sesquiterpenes. At present, 10 of our different HypPhos phosphines are commercially available
through Sigma–Aldrich; we will collaborate with them again to make our chiral phosphines and phosphine oxides
available to the scientific community. Many research groups have already used HypPhos in a variety of
enantioselective chemical catalyses. We anticipate that the proposed research will, similarly, have a significant
impact on chemical synthesis. Collectively, the catalysts and reactions developed in this project will allow the
enantioselective preparation of biologically active pharmaceuticals and natural product targets.

Public health relevance
PROJECT NARRATIVE The natural products and pharmacologically relevant compounds stemming from this project have significant biomedical ramifications, specifically in cancer, diabetes, immunology, inflammation, anesthesia, anti-HSV, anti- adenoviral, depression, and Alzheimer’s and Parkinson’s diseases.